Planar culture of gastrointestinal stem cells for screening pharmaceuticals for adverse event risk

Project Summary
GI side effects, such as ulcers and diarrhea, represent the most common source of adverse events for
pharmaceuticals. GI stem cells are responsible for repairing and replenishing GI epithelium, and pharmaceutical
inhibition of these functions likely contribute to adverse event risk. Currently there are no high-throughput and
cost-effective means of screening candidate therapeutics for effects on GI stem cells. Animal models are fraught
with confounds (e.g., rats generally do not exhibit diarrhea until death is imminent) and current in vitro models
like the Caco-2 tumor cell line do not include a normal stem cell population. While 3D-organoid cultures have a
stem cell component, access to the apical aspect of the monolayer for compound exposure is not possible
without low-throughput microinjection. Altis Biosystems, Inc. has developed a proprietary culture platform,
RepliGut® Planar, enabling primary human GI cells to form an epithelium for drug screening. In preliminary
efforts, we initiated development of a GI stem cell-specific platform called RepliGut® StemScreen to address the
unmet need for high-throughput, cost-effective GI stem cell screening, including a range of assays to measure
properties that might lead to adverse events. These included assays related to stem cell proliferation, self-
renewal, and differentiation competency.
In our Phase 1 studies, we developed a 5 day, 96-well, plate-based screening assay (termed StemTox)
and tested a panel of pharmaceutical agents known to trigger GI side effects. The results revealed a highly
sensitive and dose-dependent inhibition of stem cell proliferation and impairment of intestinal barrier formation.
Furthermore, our assay detected “adverse” concentrations for compounds that closely paralleled the clinical
plasma Cmax associated with human clinical outcomes. In this Phase 2 application, we propose to complete
optimization of the StemTox screen, generate a commercial validation data set (using multiple tissue donors and
cell lots of transverse colon), and expand the model to integrate cell differentiation and long-term drug exposures.
Collectively, this work will result in the commercial launch of the StemTox assay, as well as, enable several
follow-on experimental paradigms to more comprehensively assess off-target drug mechanisms and repeat-
dosing experiments (to parallel current IND-enabling nonclinical study requirements).

Public health relevance
Project Narrative Screening candidate therapeutics for potential adverse side effects is a key component of most preclinical studies prior to clinical testing of new drugs. However, assays using tumor-derived/transformed cell lines or small animals to test toxic effects against the gastrointestinal (GI) system are largely ineffective at predicting diarrhea, inflammation, or other adverse events. Altis Biosystems, Inc. has developed a novel platform called RepliGut® StemScreen, which allows evaluation of drugs applied to primary proliferative stem/progenitor cell populations isolated from normal GI tissues. In vivo, the stem/progenitor cells are responsible for repair and replenishment of epithelia during exposure to toxic agents or damage, but these regenerative cell types are not offered by any commercially available screening assay or platform. Enabling rapid, cost-effective, and early-stage screening of intestinal and colonic stem/progenitor cells will allow drug manufacturers to re-engineer or re-formulate therapeutics at earlier stages of development to mitigate the risk of off-target GI side effects and de-risk later stage clinical trials in humans.